Optimizing a scalable intervention to maximize guideline-recommended diabetes testing after GDM

ABSTRACT
Gestational diabetes mellitus (GDM) is a common complication that is routinely detected as part of standard
prenatal care. After delivery, women with GDM are 7 times more likely to develop type 2 diabetes than those
without GDM. National clinical guidelines thus urge completion of a 75-gram, 2-hour oral glucose tolerance test
(OGTT), given its superior sensitivity to detect diabetes, by 12 weeks postpartum. Clinical guidelines also
advise participation in an evidence-based lifestyle program for diabetes prevention. Yet uptake of this
recommended care remains low, and evidence from randomized trials on interventions to increase uptake
remains scarce. Here, we propose to test a novel, multi-component outreach intervention that explicitly targets
as-yet neglected, patient-level motivational and logistical barriers to engaging in preventive care during the
demanding postpartum period. We will leverage the multiphase optimization strategy (MOST) to identify, in a
randomized factorial trial, which of four theory-driven components increase actual completion of postpartum
screening and enrollment in lifestyle programs for diabetes prevention: 1) a streamlined values affirmation, 2)
personalized information about diabetes risk, 3) an interactive motivational interviewing-based module, and 4)
an interactive action planning module. Each component is designed to be self-directed and delivered securely
online via existing infrastructure in a health system setting, increasing its future potential for large-scale reach.
In a racially and ethnically diverse sample of women with GDM within the Kaiser Permanente Northern
California (KPNC) health system, our specific aims are as follows. Aim 1: Identify which of four components of
the outreach intervention increase completion of a) a 75-gram, 2-hour OGTT within 4-12 weeks postpartum,
aligned with national clinical guidelines (primary outcome), and b) any postpartum diabetes screening test
(OGTT, fasting plasma glucose, or hemoglobin A1c) by 52 weeks postpartum (secondary outcome). Aim 2:
Identify which of four components of the outreach intervention increase enrollment in a health system- or
community-based lifestyle program for diabetes prevention by 52 weeks postpartum (secondary outcome). Aim
3: Determine whether each intervention component impacts its target mediator, as predicted by its respective
theory. We will efficiently and objectively assess screening outcomes via electronic health records. Results will
yield an optimized intervention ready to be tested in a future pragmatic trial to accelerate uptake of guideline-
recommended postpartum care for women with GDM, with the long-term goal of preventing diabetes in a
diverse and high-risk clinical population.

Public health relevance
PROJECT NARRATIVE Women with gestational diabetes mellitus (GDM), a common pregnancy complication, face elevated risk for later developing type 2 diabetes. Health professionals recommend that women with GDM be screened for diabetes after delivery and participate in lifestyle programs to help prevent type 2 diabetes; however, most women do not receive these services. This study will develop an outreach strategy to help maximize the number of women with GDM who take advantage of health services for type 2 diabetes prevention.